Core B: Clinical Core

The Clinical Core will support the ADRC’s objectives by maintaining about 500 research participants,
who agree to longitudinal follow-up and undergo a detailed evaluation every year. The research participants
include people who have no cognitive problems and are aged 65 or older (healthy controls), people with mild
cognitive symptoms (Mild Cognitive Impairment, or MCI) and people with Alzheimer’s Disease, other
neurodegenerative diseases (e.g., Dementia with Lewy Bodies or Frontotemporal Dementia) or vascular
cognitive impairment. Participants are recruited from across San Diego County and from neighboring parts of
Orange and Riverside Counties. At least 20% of the cohort will be Latino, supporting diversity among the
cohort and a research focus of the Center on better understanding risk and protective factors for AD and
related disorders among Latinos, the second largest ethnic group in San Diego. The evaluation includes history
of cognition, behavior and function, medical and family history and medications. A general and neurological
examination is performed. Participants undergo neuropsychological testing of memory and other cognitive
abilities. Blood is drawn for routine laboratory tests and to prepare samples for measurement of biomarkers
and for DNA analysis. Participants undergo brain imaging by MRI, and some will also have PET scans of the
brain to assess for accumulation of the amyloid and tau proteins. If they agree, participants will also undergo a
research lumbar puncture, where cerebrospinal fluid is removed for testing and to support research. Data
generated from all of these procedures and studies is entered into the ADRC database. The ADRC research
team reviews all the clinical and cognitive data to make an initial clinical diagnosis. They then assess CSF,
brain imaging and blood biomarkers to determine whether Alzheimer’s Disease or other disorders may be
present and account for the participant’s symptoms. Participants are approached to donate their brains at the
time of death to support further research.
Data from the annual assessments are shared with the National Alzheimer’s Coordinating Center
(NACC), plasma and DNA are shared with the National Central Repository for Alzheimer’s Disease (NCRAD)
and brain images are shared with the SCAN project; this sharing makes UCSD data, samples and images
available to support large scale research across the national ADRC network. ADRC participants are also
offered participation in additional research projects with collaborators at UCSD.